Accelerating nerve regeneration with botulinum toxin and electrical stimulation therapies

Project Summary
Peripheral nerve injuries are an under-appreciated public health problem. There are about
200,000 new cases per year in the USA. Recovery is incomplete for the vast majority of patients
who suffer from one because nerve regrowth is slow and inefficient. Unfortunately, there are no
approved treatments to improve the process of nerve regeneration. We have identified two
complimentary therapies in order to target the (i) early and (ii) late phases of the nerve
regeneration process. They each may work as stand-alone therapy or potentially in
combination, as we predict they will have an additive benefit on nerve repair. The present
proposal will set the stage for a follow up clinical trial to bring the most promising therapy to
patients. We believe we can make rapid progress towards this goal because one therapy
represents a repurposing of an already FDA-approved drug, and the other therapy is a form of
electrical stimulation that already has shown efficacy in small clinical trials for nerve injury. The
electrical stimulation therapy is in need of a new mode of delivery to remove barriers to clinical
implementation, which we offer by means of novel transient bio-electric implant system. Overall,
this proposal will deliver a new horizon in how we can improve the treatment of patients with
peripheral nerve injuries to maximize their functional recovery.

Public health relevance
Project narrative Peripheral nerve injuries are an under-appreciated public health problem, despite 200,000 new cases per year in the USA. Recovery is incomplete for the vast majority of patients who suffer one because regrowth is slow and inefficient, and there are no approved treatments to improve the process of nerve regeneration. The goal of this project is to develop new therapies to specifically target the major events of the nerve regeneration process using a repurposed drug as well as a novel bio-electronic implant sytem.